PBS NewsHour Health Literacy and Student Reporting Labs: Broad expansion of journalism to increase bioscience literacy in America and support the next generation of biomedical science communicators

PBS NewsHour Student Reporting Labs will produce a series of high school student journalist virtual interviews with researchers working to understand and fight the COVID19 pandemic. These interviews will highlight the role of student journalism in improving the health STEM literacy of teenagers and the public; connecting students to biomedical and clinical research career pathways and spotlighting the role of health research in education, policy decisions, and civic life. Videos will be edited by Student Reporting Labs youth media producers and published on social media and digital public media platforms to broad audiences of teenagers and adults.

Public health relevance
PUBLIC HEALTH RELEVANCE: To increase public health literacy, all sectors of society must have access to the highest-quality health science news and information possible, suited to their learning needs, cognitive capacities, and health concerns. Translation, packaging and broad dissemination is important to this goal: the stories matter. PBS NewsHour, the most trusted news in America, is ideally positioned to raise the level of discourse and decision making around public health issues through production of targeted health news stories and emerging issues in the biomedical field. Through SEPA funding, adaptation of PBS NewsHour's Student Reporting Labs and youth mentoring program has the potential to address health disparities and science literacy deficits and to build a new cadre of minority youth and youth from low socio-economic status communities who will have the discipline, creativity and critical thinking skills needed to be successful health science-literate citizens and advocates in their communities and for their peers.